Jumpstarting Culturally-informed Advance Care Planning with ANAI People in Primary Care

Chronic disease causes the most death and disability in the United States (US), and American Indian/Alaska Native people (ANAIs) are more likely than other demographic groups to die of heart disease, diabetes, chronic lower respiratory disease, cirrhosis, stroke, pneumonia, kidney disease, and hypertension. Among ANAIs age 55 and older, 90% have at least one chronic condition, compared with 78% of their US peers. As the older ANAI population rapidly increases, with higher rates of serious illness than the general population, there is an urgent need for strategies to provide tailored palliative and end-of-life care interventions for seriously ill ANAIs. However, ANAIs are far less likely than their US peers to use palliative care, including advance care planning (ACP), which involves discussing patient values and goals to align care with patient preferences. ACP leads to better outcomes for patients, their families, and health systems, including decreased depression, anxiety, and grief, fewer non-beneficial end-of-life treatments, and reduced cost. ACP is typically documented in advance directives (ADs) that specify patient preferences for life-sustaining treatments and who can make medical decisions on their behalf. Yet, less than a third of seriously ill US adults have ADs, and ANAIs age 55 and older are only half as likely to have ADs as their peers in other demographic groups. Previous research suggests that ANAIs will engage in ACP and complete ADs when given access to timely and tailored ACP conversations, but no ACP communication interventions have been rigorously tested with ANAIs. Our team used community engagement methods to tailor an ACP communication intervention and pilot the tailored intervention—Jumpstart ANAI—with 68 seriously ill adult ANAIs at Southcentral Foundation (SCF), an Alaska Native health system. We recruited 97% of the target sample (n=70) and retained >75% of patients at follow-up. We also found that 95% of patients stated that Jumpstart ANAI helped them to have ACP conversations with their primary care providers. This project expands upon a strong scientific research partnership to implement Jumpstart ANAI in the Alaska Tribal Health System (ATHS) and evaluate it using an innovative type 1 hybrid effectiveness-implementation approach. Our specific aims are to: 1) Engage stakeholders to tailor an implementation plan for the health system that integrates Jumpstart ANAI into routine primary care practice; 2) Conduct a cluster-randomized trial with 40 primary care providers and 280 seriously ill ANAI patients to test the effectiveness of Jumpstart ANAI for increasing ACP as compared to usual care; and 3) Conduct a rigorous mixed-methods process evaluation using the Consolidated Framework for Implementation Research to assess challenges and facilitators to implementing Jumpstart ANAI system-wide. Improving access to and delivery of tailored, evidence-based ACP is a high priority for ATHS leaders and community members. By evaluating the effectiveness of a tailored ACP intervention and implementing the intervention in routine care, this study will provide critical evidence for improving chronic illness care for seriously ill ANAI people and their families.

Public health relevance
PROJECT NARRATIVE The older Alaska Native/American Indian (ANAI) population is increasing at more than twice the rate of the general population and has higher rates of chronic illness. Yet, older ANAIs are only half as likely to have advance directives (AD), indicating a need for advance care planning (ACP) to ensure that care aligns with patients’ values and goals. This project will implement and evaluate a culturally tailored ACP intervention to increase ADs among seriously ill ANAI patients and provide evidence for improving palliative and end-of-life care delivery to this rapidly rising population of Americans.